LONG TERM, OPEN LABEL TREATMENT INVESTIGATIONAL NEW DRUG FOR MULTIPLE

This study is to evaluate the safety of Copaxone and monitor the neurologic course of disease in Multiple Sclerosis patients treated with Copaxone. Currently patients are being followed in a long term open-label extension. They are being followed by MRI.